Understanding the Effect of Climate Change on Road Safety in Ghana

In this response to NOT-TW-22-003, we propose an administrative supplement to D43 TW007267
(Strengthening Injury Control Research in Ghana and West Africa). This supplement is entitled
“Understanding the effect of climate change on road safety in southern Ghana”. This supplement on
climate change and health (CCH) is within the scope of our D43 training grant in injury research as: (1)
our mentors and scholars have conducted extensive research on road safety in Ghana and thus our program is
well poised to undertake similar research on the effects of climate change on road safety; (2) injury control
addresses a wide spectrum of biomedical research issues, including identifying and quantifying risk factors,
and thus addressing climate change is a natural extension of such work; and (3) our 17 year experience in
training and mentored research is flexible, multifaceted, and eminently applicable to CCH.
Broad goal: To strengthen the capacity for research on climate change and health at the Kwame Nkrumah
University of Science and Technology (KNUST), by engaging junior researchers in innovative, mentored
research to better understand the effect of climate change on road safety in Ghana.
Specific aim 1: Using existing data on police-reported crashes, to determine whether the proportion of all
crashes during the year that occur during those months most associated with extreme weather (the rainy
season - June-July - and the dry season - January-February) has increased over the past 30 years.
Specific aim 2: Through interviews with 400 commercial drivers, assess what climatic hazards commercial
drivers have noticed, especially during the rainy and dry seasons, and how these hazards may have changed
during the past 10 years.
Specific aim 3: To obtain twice-weekly baseline measurements of important meteorological parameters
(rainfall, humidity, temperature, dust concentration, and aerosol optical depth – a measure of visibility) that
affect road safety, at 5 crash hot-spots in southern Ghana, during 6 months. The specific months will be: dry
season (January-February), rainy season (June-July), and two interim months (April, November). These will
establish baseline measurements for future monitoring and research.

Public health relevance
The proposed administrative supplement will provide for research on the potential effects of climate change on road safety in Ghana. The proposed research projects will serve as research training for three students at the Kwame Nkrumah University of Science and Technology in Kumasi and will help to strengthen that institution’s capacity for research on climate change and health.